Mechanisms of VSM dysfunction in diabetes and HFpEF

Abstract .
Vascular complications associated with lifestyle-related diseases, such as diabetes, contribute to an increased
risk of hypertension, coronary artery disease, and heart failure associated with preserved ejection fraction
(HFpEF). These vascular complications may involve, at least in part, vascular smooth muscle (VSM) dysfunction
leading to impaired vasomotor function, but mechanisms remain poorly understood. We recently identified a
novel AKAP5/P2Y11/AC5/PKA/CaV1.2 nanocomplex that is activated by the release of extracellular nucleotides,
such as ATP. This complex controls VSM contractility, vasoconstriction, and altered blood flow (BF) and blood
pressure (BP) in response to elevated extracellular glucose (e.g. hyperglycemia; HG – a major metabolic
abnormality in diabetes). Yet, whether HG stimulates cellular nucleotide release, the precise molecular entity
underlying this process, and its potential role in diabetes and other diseases (e.g. HFpEF) are unknown. The
overarching goal of this MPI proposal is to provide insight into these issues. Our preliminary data offers a
unique window into these queries and uncover an essential role for the large-pore channel pannexin 1 (Panx1)
as a key member and upstream protein activating the nanocomplex and thus contributing to altered vascular
reactivity during diabetes and perhaps other diseases such as HFpEF. We will address the novel central
hypothesis that Panx1 is upstream and part of the AKAP5/P2Y11/AC5/PKA/CaV1.2 signaling axis that promotes
VSM contractility and altered BF/BP in response to diabetic hyperglycemia. The proposal has high significance
as it defines Panx1 as 1) a key upstream pathway triggering pathological signaling resulting in VSM
hypercontractility during diabetic hyperglycemia and 2) a potential therapeutic target to treat vascular
complications in diabetes (and perhaps HFpEF). The influence of Panx1 in contributing to the ATP release in
response to HG, and in strengthening/weakening the formation of nanocomplexes to mediate functional
responses, which may have broader implications in any Panx1-dependent signaling process, is an emerging
and innovative concept. Our innovative multi-scale approach using state-of-the-art approaches will be
implemented to explore the following aims. Aim 1 is to elucidate the role of Panx1 on HG signaling in VSM. Aim
2 is to determine the impact of Panx1 on VSM dysfunction during diabetes and HFpEF. The impact of the
proposal is in establishing Panx1 as a key contributor to defective VSM function and vascular complications in
diabetes and HFpEF.

Public health relevance
Project Narrative . It is well appreciated that vascular complications associated with lifestyle-related diseases, such as diabetes, contribute to an increased risk of hypertension, coronary artery disease, and heart failure associated with preserved ejection fraction (HFpEF). Yet, mechanisms, especially those underlying vascular smooth muscle dysfunction, are poorly understood. This proposal addresses these fundamental knowledge gaps and fulfills relevant public health goals and NIH missions by generating fundamental basic knowledge that could help identify and develop novel treatment strategies to address vascular complications associated with diabetes and HFpEF.